Defining the cause and consequence of aging-specific platelet specification from hematopoietic stem cells

PROJECT SUMMARY/ABSTRACT
Our goal is to understand platelet (Plt) production and function upon aging. Plts play essential roles in
hemostasis, the process of preventing bleeding, and also participate in immune regulation. Aging is associated
with a dramatic increase in platelet-related disorders, including alterations in Plt numbers (thrombocytosis or
thrombocytopenia) and in Plt activity. Plts have a very short half-life and are continually produced by
hematopoietic stem cells (HSCs). We have discovered that the differentiation pathways of Plt production are
different in young and old mice. Here, we propose to investigate the molecular and cellular mechanisms behind
the aging-specific differentiation path, and the consequences for Plt function and aging physiology. We
hypothesize that the aging-specific Plt pathway contributes to the dramatically increased risk for Plt-related
disorders in the elderly. Our discovery of a new, age-specific differentiation pathway provides a unique
opportunity for novel discoveries towards mitigating Plt-related disorders, including thrombosis and
cardiovascular disease, in the elderly.

Public health relevance
PROJECT NARRATIVE This proposal will investigate the mechanisms regulating the production and activity of platelets, the main mediators of blood clotting. We aim to understand how platelet generation is altered during aging. The findings will inform strategies for mitigating platelet-related disorders such as stroke and thrombosis that frequently plague the elderly.